Genetic dissection of motivational drive to eat

Project Summary/Abstract
Please see 2-page Research Strategy for Project Summary/Abstract.

Public health relevance
Project Narrative Please see 2-page Research Strategy for Project Narrative.